Role of codon usage bias in eukaryotic evolution and regulation

PROJECT SUMMARY
Codons and tRNAs are key components of the central dogma, and changes in the abundance of either can lead
to significant cellular changes. While perturbations of the balance between codon usage and tRNA have been
explored, little is known about how natural systems harness this potential regulatory system. This is a gap in
our understanding of basic cellular biology, and there is the potential for erroneous evolutionary conclusions
based on methods that assume neutrality in synonymous changes. The work proposed here will advance our
understanding of the extrinsic factors shaping this phenomenon and the dynamics occurring within the cell.
The budding yeast subphylum (Saccharomycotina) is an ideal model for studying tRNA and codon dynamics.
Our recent collaboration has produced draft genomes, annotations, and a phylogeny for 1,154 budding yeasts
representing >400 million years of evolutionary history. We also have phenotypic growth curves for over 800
species. Additionally, the budding yeasts have long been a model system for cellular biology and there are many
genomic tools available for experimentation. This biological treasure trove has plentiful data for modern
machine-learning methods and is genetically tractable for extensive experimentation.
The first aim will unravel the association between evolutionary rate, growth rate, and expression level through
the lens of codon usage. The current paradigm is that an increased growth rate is accompanied by increased
amino acid and potentially synonymous mutation rates. These traits, however, both impact gene expression
levels. The budding yeast subphylum provides a unique opportunity to simultaneously examine the evolution
of these three traits as they vary widely across the group. The computational models will be accompanied by
experimental work that modulates growth rate by altering transcriptional codon usage and the tRNA pool.
The second aim will explore how the codon bias of transcribed genes is tuned to or by the tRNA pool. First, we
will test the hypothesis that co-regulated genes have coordinated codon usage profiles using machine learning
methods. Novel co-regulatory hypotheses generated will be experimentally verified. This work will be
complemented by a large sequencing endeavor to produce tRNA, mRNA, and ribosomal sequencing data to
capture transcriptional codon usage bias fully. This unique dataset will allow us to address the hypothesis that
the transcriptional codon usage landscape is dynamic during regulatory changes.
The LaBella lab group is ideally poised to address these critical hypotheses about the dynamics and impact of
tRNA and codon biases. Our expertise in the fields of codon usage analysis and tRNA biology complements our
skills in machine learning and fungal experimentation. These proficiencies will allow us to test diverse
hypotheses on codon usage and tRNA dynamics. This research will impact many other fields that leverage
evolutionary rates, require heterologous protein expression, or try to identify regulatory schemes.

Public health relevance
PROJECT NARATIVE Despite being a key step in the central dogma of biology, there are major gaps in our knowledge of the dynamics and downstream effects of the interaction between codons and tRNAs. This project explores the evolutionary and cellular consequences of codon biases and tRNA fluctuations. The findings of this work are critical to the construction of evolutionary models and our understanding of cellular regulation.